Linker histone H1 and variant histone H2A.Z interactions in gene silencing and chromosome segregation

Project Summary/Abstract
Linker Histone H1 and Variant Histone H2A.Z interact to regulate transcriptional
silencing and chromosome segregation in budding yeast
H1 and H2A.Z are highly conserved building blocks of eukaryotic chromosomes that
promote e=icient patterns of gene expression and transmission of chromosomes. Our
published and preliminary data indicate that a balance of H1 and H2A.Z function is
required for diverse chromatin-mediated processes in the cell, including heterochromatin-
dependent transcriptional silencing and kinetochore function. In particular, our results
suggest that H2A.Z protects the cell from a potentially deleterious action of linker histone
H1. To uncover fundamental aspects of chromatin structure and determine speciﬁc
functions of histone H1 and H2A.Z we will conduct a series of experiments to determine
the nature of this relationship. We will conduct chromatin immunoprecipitation
experiments to determine the interdependence of H1 and H2A.Z’s binding through the
genome, including across heterochromatic regions and centromere-associated
sequences. We will examine histone H1’s possible association with silencing factors, and
determine if increases in chromosome ploidy observed in strains lacking H2A.Z are due to
an H1 inﬂuence on kinetochore structure or function.

Public health relevance
Project Narrative The DNA in all our cells is protected and regulated by chromatin proteins. We are investigating the defects in DNA function that arise when the chromatin proteins histone H1 and histone H2A.Z are not in balance. This imbalance leads to defects in gene expression and chromosome stability; similar defects underlie a large number of disease states.